Project-005

ABSTRACT
This supplement does not alter the scope of work described in the parent Abstract for P30CA013148.

Public health relevance
PROJECT NARRATIVE This supplement does not alter the scope of work described in the parent Narrative for P30CA013148.